Training Core

The Training Core is designed to specifically support and direct the interdisciplinary training in environmental health sciences of four graduate students, four postdoctoral fellow and seven undergraduate interns. Core activities are also expected to foster interdisciplinary training of other interested undergraduate and graduate students at Dartmouth. Individuals sponsored by this core are expected to conduct programspecific research and are encouraged to work on interdisciplinary projects that involve interactions with other projects and personnel within the program beyond the mentor's laboratory and area of expertise. The collaborative and interdisciplinary nature of the six projects and three scientific support cores of this Program naturally foster development of such interactive projects. The other activities of the training core include: participation in the program-sponsored and organized seminar and symposium series; the Dartmouth SBRP quarterly and bi-annual scientific meetings in which students and post-doctoral associates present and discuss research-in-progress with the entire program staff; five graduate courses which are sponsored, organized and taught by the faculty of the program; participation in local, regional and national scientific meetings where they are encouraged to present their results to other SBRP Programs and to the larger scientific community; fostering of interactions with NIEHS, EPA and other stakeholders; active participation in the various translation and outreach activities of the program; and other program-associated training activities. The graduate and undergraduate students and postdoctoral fellows trained by this core collectively represent more than a dozen individuals who are working in various labs of the six scientific projects and three research support cores. The Director will oversee the conduct of this program with the assistance of Professor Dean Wilcox (Project 5 Leader) and the Executive Committee.